Exacerbation of Colitis by Enterobacteriaceae

ABSTRACT
Ulcerative colitis is a complex disease caused by a combination of genetic risk factors,
childhood exposure to environmental risk factors and a poorly defined microbiota component.
Ulcerative colitis is associated with imbalance in the microbiota (dysbiosis) characterized by
increased Enterobacteriaceae and reduced Clostridia abundance. Ulcerative colitis can respond
to antibiotic treatment, which suggests that dysbiosis exacerbates intestinal inflammation, thus
raising the question as to how microbiota homeostasis can be restored. Our preliminary data
suggest that epithelial hypoxia and epithelial release of hydrogen peroxide represent host control
mechanisms that maintain homeostasis in the colon and that facultative anaerobic
Enterobacteriaceae exacerbates colitis when these host control mechanisms become weakened
by a combination of genetic and environmental risk factors. Our central hypothesis is that
increased epithelial oxygenation drives an expansion of facultative anaerobic Enterobacteriaceae
that exacerbate colitis because members of this family are not excluded by growth conditions
encountered in close proximity to the epithelial surface. In specific aim 1 we will test the working
hypothesis that rebalancing the gut microbiota by reinstating epithelial hypoxia represents a
feasible approach for restoring gut homeostasis. In specific aim 2 we will determine how
Enterobacteriaceae exacerbate colitis in mice carrying a genetic risk factor while being exposed
to a combination of environmental risk factors. Successful completion of the proposed work will
be of broad significance for research on microbial ecology in the gut, the dynamics of gut-
associated microbial communities during inflammation and the pathogenesis of ulcerative colitis.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Ulcerative colitis is associated with an imbalance in host-associated microbial communities (dysbiosis), but the mechanisms involved in disrupting homeostasis and the consequences of a microbial imbalance for human health remain poorly defined. Here we will study the mechanisms through which colitis drives an expansion of potentially harmful bacteria in the colon and how this bacterial bloom escalates colitis. The resulting knowledge will usher in important conceptual advances on how the host maintains homeostasis in the gut, which will have a strong potential to exert a high impact on research in this field.